Administrative Supplement: Summer undergraduate research:Imaging the Molecular Forces Generated by Synthetic Motors

This document is not required for this Submission.

Public health relevance
This document is not required for this Submission.